Integrating Clinical Knowledge: A Multimodal AI System for Reliable Head CT Understanding and Interpretation

SUMMARY
The field of radiology is undergoing a significant transformation with the integration of artificial
intelligence (AI), particularly in head computed tomography (CT) scan interpretation. While AI
systems are evolving from narrow-task solutions to comprehensive systems for detecting
multiple findings and generating preliminary reports, we lack robust frameworks for evaluating
their accuracy across both radiological observations and diverse clinical scenarios. This project
advances head CT interpretation through three interconnected approaches focused on
knowledge representation, image-based report verification, and longitudinal analysis of
sequential scans. We propose developing a comprehensive knowledge graph and similarity
metric for standardizing radiological concepts, leveraging large language models to create more
granular taxonomies than existing medical ontologies. Additionally, we will implement an
AI-enabled verification system for real-time assessment of radiology reports, employing
uncertainty estimation and visual entailment models to verify factual accuracy of statements
against imaging findings. In addition, we will develop novel methods for automated longitudinal
comparison of sequential head CT scans, addressing the challenge of tracking multiple findings
across complex neuroanatomical structures. This will enable both quantitative measurements
and qualitative assessments of temporal changes. The project leverages datasets from multiple
health systems and brings together expertise in biomedical AI, radiology, neurology, and
neurosurgery. Our work will establish essential foundations for reliable AI-assisted head CT
interpretation, enhancing radiologist trust and improving patient care through more accurate and
verifiable reporting systems.

Public health relevance
PROJECT NARRATIVE Current artificial intelligence (AI) systems for head computed tomography (CT) interpretation lack rigorous frameworks to validate their accuracy and reliability when analyzing multiple findings across diverse clinical indications. We propose a multi-pronged approach that advances AI-assisted head CT analysis by developing a knowledge graph to standardize report terminology, creating systems to verify AI-generated report statements against source images, and enabling automated detection of clinically significant changes between current and prior scans. This work will establish foundations for reliable AI-assisted CT interpretation, strengthening radiologist confidence and improving patient care through verifiable reporting systems.